Mitochondrial Defects in 22q11.2 Deletion Using a Human-Derived Neuronal Stem Cell Model

ABSTRACT
The 22q11.2 Deletion (22qDel) is the most common microdeletion syndrome and confers a high risk for
developing schizophrenia. Though the etiology of schizophrenia remains unclear, accumulating evidence
supports the hypothesis that mitochondria are adversely impacted. Mitochondria are known to provide
extensive support for the highly specialized and localized functions of neurons. Interestingly, several 22q11.2
locus gene products localize to mitochondria and are decreased in 22qDel. SLC25A1 and MRPL40, two of the
22q11.2 mitochondrial genes, have recently been found to interact biochemically and genetically. Therefore,
22qDel may impact neuronal development by compromising mitochondrial function. Our lab has generated
isogenic 22q11.2 induced pluripotent stem cells from neurotypical controls and differentiated these lines to
various 2D and 3D neuronal models. The overall objective of this project is to determine how mitochondria
are impacted in 22qDel in developing neural tissue and to assess potential key putative driver genes. My
central hypothesis is that the loss of 22q11.2 mitochondrial protein disrupts mitochondrial development and
functionality and certain mitochondrial proteins, such as SLC25A1 and MRPL40, interacts to drive the
assembly and integrity of mitochondrial ribosomal machinery and translation and are dysregulated in 22qDel.
Aim 1 will quantify global mitochondrial function in live cell respiration assays and determine the protein
expression of various OXPHOS subunits in developing neural cells and tissues. I will then quantify the
differences in mitochondrial quantity, morphology, and membrane potential in subcellular neuronal
compartments. Aim 2 will determine the impact of reduced expression of both SLC25A1 and MRPL40 on
mitoribosomal integrity and expression and local/mitochondrial protein synthesis using short hairpin RNA
(shRNA) in iPSC-derived neurons. These aims will inform our understanding of the impact of 22q11.2 deletion
on mitochondria and neuronal development, which may provide novel insights into the shared biology of
schizophrenia.

Public health relevance
22q11.2 deletion (22qDel) is a high-risk schizophrenia-associated microdeletion. Several nuclear-encoded mitochondrial proteins are located within the 22q11.2 locus prompting the hypothesis that neuronal mitochondria may be particularly vulnerable to heterozygosity of 22q11.2 genes. This project will determine the impact of the 22q11.2 deletion on mitochondrial biology and neuronal development and may provide novel insights into its shared biology with schizophrenia.